Wake Forest NCORP Research Base

The overarching goal of the Wake Forest NCORP Cancer Center Research Base (WF NCORP RB) is to improve
patient well-being and the quality of cancer care by developing, implementing and successfully completing
innovative and feasible Cancer Control and Cancer Care Delivery (CCDR) clinical research studies. For nearly
two decades as a CCOP and now NCORP Research Base, Wake Forest has maintained an exclusive focus on
Cancer Control and CCDR studies and has emphasized efficient operational processes and extensive
interactions with our NCORP Community Site and Minority Underserved Community Site partners. During the
first 4 years of the NCORP network, the WF NCORP RB: opened 7 Cancer Control and 3 CCDR studies; enrolled
1,140 participants on WF NCORP RB studies; obtained approval for 5 additional concepts and protocols bringing
the total remaining and planned accrual for active and pending trials to over 4,420 participants; and achieved a
33% accrual rate of racial/ethnic minority participants, as well as 68% women, 14% rural residents and 26% age
65 or greater. Over the next 6 years, we will build on and strengthen this highly successful platform by
accomplishing the following Specific Aims: Specific Aim 1: Extend our cancer control clinical research activities
in the following areas: cardiovascular complications of cancer therapy; radiation and chemotherapy-induced
neurocognitive toxicities; and additional cancer and treatment-related symptoms and related-outcomes
prioritized by NCI steering committees and those commonly associated with novel emerging treatment
paradigms. Specific Aim 2: Elucidate and intervene upon patient, family, clinician, and organizational factors
that influence cancer care delivery, emphasizing survivorship care, informal cancer caregivers and
implementation of evidence-based supportive care services. Specific Aim 3: Illuminate biological mechanisms
underlying cancer and treatment-related symptoms and toxicities in new and innovative multidisciplinary
collaborative studies taking advantage of our growing biobank of blood, urine and salivary fluid specimens.
Specific Aim 4: Identify and address determinants of cancer disparities via disparities-focused studies,
integrated aims focused on underserved populations, and targeted recruitment of racial and ethnic minority and
underserved populations across all Wake Forest NCORP research investigations. Specific Aim 5: Train the
next generation of Cancer Control and CCDR researchers through mentoring and involvement of early career
faculty, oncology trainees, post-doctoral fellows, and students in WF NCORP activities. Our ongoing and
proposed Cancer Control and CCDR studies will continue to improve oncology care by informing best practices
for symptom and late effect management as well as efficient, patient-centered, evidence-based cancer care
delivery for diverse patient populations. In the next funding period, the WF NCORP RB will help accelerate the
translation of knowledge in cancer control and cancer care delivery through close partnership with community
and minority underserved sites and studies designed for future dissemination and implementation.

Public health relevance
The Wake Forest NCORP Research Base develops and implements multi-site Cancer Control and Cancer Care Delivery (CCDR) clinical research studies in partnership with NCORP Community and Minority/Underserved Community Sites to improve patient well-being and the quality of cancer care.